A no-gold-standard framework to objectively evaluate quantitative imaging methods with patient data

Project Summary
Quantitative imaging, where a numerical/statistical feature is computed from a patient image, is emerging as an
important tool for diagnosis and therapy planning. Several new and improved quantitative imaging (QI) methods,
which include reconstruction, analysis, and estimation methods are thus being developed. There is an important
and timely need to optimize the QI methods on the underlying clinical quantitative task, as sub-optimal methods
would yield quantitative values that are unreliable, and thus have limited clinical value. Performing this evaluation
with patient imaging data is highly desirable, but the unreliability or unavailability of a gold standard for most
patient studies makes evaluation impractical or impossible. To enable evaluation of imaging methods with patient
data, several no-gold-standard evaluation (NGSE) techniques have been developed, but mostly in the context
of detection tasks. More recently, similar NGSE techniques for quantitative tasks have been developed by us
and others. We have demonstrated the efficacy of our NGSE technique in ranking segmentation methods for
diffusion MR and reconstruction methods for quantitative SPECT. Our goal in this project is to take steps towards
translating this mathematical concept to a clinical tool. Existing NGSE techniques make assumptions that may
not hold in several QI applications, require large amounts of patient images that are often unavailable, and have
been validated using only computational studies. To address these issues, we propose to develop and
comprehensively validate a novel generalized Bayesian NGSE framework. This framework will be a generalized
Bayesian approach that will reflect clinical scenarios accurately and not require multiple patient studies. The
framework will be validated using new anthropomorphic physical phantom and patient data in addition to realistic
and validated simulation studies. For clinical translation, it is also necessary to demonstrate the efficacy of the
framework in answering an important clinical question. The clinical question we choose is that of using the NGSE
framework to determine the optimal segmentation method to compute volumetric features from PET for early
prediction of therapy response in patients with non-small cell lung cancer (NSCLC). Answering this question will
help address a critical, urgent and unmet need for strategies to personalize the treatment of NSCLC, a disease
with high morbidity and mortality rates. The proposed NGSE framework is well poised to accelerate the clinical
translation of new and improved QI methods by enabling their evaluation with patient data. The framework will
have multiple high-impact applications such as in determining the optimal QI method for measuring biomarkers
to monitor cancer-treatment response, diagnose cardiac/neurodegenerative diseases, and conduct imaging-
based dosimetry. Thus, developing this NGSE framework has the potential to significantly impact QI-based
clinical decision making.

Public health relevance
Project Narrative There is an important need to develop techniques for objective clinical evaluation of quantitative imaging methods without a gold standard. The proposed project will design and rigorously validate such methods in the context of developing PET biomarkers for predicting therapy response in patients with non-small cell lung cancer. Our long-term goal is clinical translation of these methods. The developed methods are general and applicable to other diseases where quantitative imaging has a role, such as neurodegenerative and cardiac diseases.